Biomarker and Metabolomic Investigations in ALI

DESCRIPTION (provided by applicant): The overall objective of this project is to enhance our understanding of acute lung injury (ALI) pathogenesis and to expand the potential utility of biomarkers and metabolomic analysis. Acute lung injury (ALI) is a life- threatening disease that affects 200,000 people each year in the US and, because there is no defined medical therapy, mortality rates remain high. Our ability to determine which at-risk patients will progress to ALI i limited, and although specific biomarkers have been identified, there remain unanswered questions about how these biomarkers contribute to ALI pathogenesis. RAGE is a marker of alveolar epithelial lung injury, and elevated levels of soluble RAGE (sRAGE) have been identified in the BALF of patients with ALI when compared to non-ALI patients. However, the RAGE activation pathway is complex and there is limited data explaining the mechanism of sRAGE entry into the alveolar space. HMGGB1 and MMPs have been implicated in the RAGE pathway; however, data showing that all these markers are concomitantly increased in ALI is unavailable. Analyzing specimens from the NHLBI biologic specimen repository allows us to confirm and extend our initial observations about sRAGE and active metabolite patterns. We propose to test the hypothesis that sRAGE, HMGB1 and MMP-3 and -13 work as a functioning unit and changes in levels over time in ALI patients will be associated with mortality. We will extend this data using metabolomics to show that specific metabolic pathways are associated with biomarker activation and survival status. The specific aims are designed to : 1) test the hypothesis that sRAGE, HMGB1 and MMPs are coordinately increased in the BALF of patients with ALI compared to controls at risk for ALI; and determine whether sustained increases in sRAGE, HMGB1 and MMP levels over time are associated with mortality in ALI patients; and 2) develop a high- resolution metabolomic database for ALI linked to outcomes in order to: determine the association between specific metabolomic pathways and biomarkers analyzed in Aim 1, and identify candidate metabolites that differentiate ALI survivors and non-survivors. To test our hypotheses we will analyze BAL samples from the NHLBI biorepository obtained from the ARDSnet LaSRS trial, which provides BALF collected at two different time points. As a control population, we will also obtain BALF from mechanically ventilated patients with an at- risk diagnosis for ALI. We will perform assays measuring HMGB1, MMP-3 and -13, and sRAGE both in BALF. Metabolomic profiling of ARDS patients will be performed via high-resolution mass spectrometry. The long- term goal is to develop an affordable approach that can be used for predicting disease susceptibility, diagnosis, risk stratification, response to therapy and prognosis.

Public health relevance
Project Narrative: Acute lung injury (ALI) is a common, potentially lethal disease that occurs in critically ill patients and for which there is no effective treatment. Enhancing our understanding of the biological mechanisms that lead to the development of lung injury is imperative for the purpose of developing effective new therapies. The proposed research will provide new information about biomarkers and metabolomic profiles in ALI, and will evaluate the use of these markers for prognostication. __SpecificAimsTextDelimiter__ Specific Aims: Acute lung injury (ALI) is a life-threatening disease that affects approximately 200,000 people each year in the US. There is no pharmacological therapy for ALI and mortality rates remain high. Not all critically ill patients develop ALI, and our ability to predict either the development or outcomes of ALI is limited. Biomarkers have improved our understanding of disease pathogenesis and with the availability of the NHLBI repository, we have the opportunity to investigate biomarker mechanisms, and implement metabolic profiling to identify pathways contributing to disease pathogenesis. Various biomarkers have been implicated in ALI, and studies have begun to shed some light on the mechanisms leading to injury and delayed repair. The receptor for advanced glycation endproducts (RAGE), a member of the immunoglobulin superfamily, has been found to be a biomarker of ALI. The soluble form of RAGE, (sRAGE), is increased in the bronchoalveolar lavage fluid (BALF) of patients with ALI when compared to non-ALI patients, a finding that we recently confirmed in patients with sepsis-induced ALI. However, there remains much to learn about the actions of sRAGE and the factors that influence its production. Very few studies have addressed this, but so far have demonstrated that sRAGE production is individually modulated by the high-mobility group box-1 (HMGB1) proteins, and the matrix metalloproteinases-3 and -13. To elucidate the relationship of these biomarkers to disease phenotype and outcome, we have the opportunity to analyze BALF samples from ALI patients collected in the ARDSNet Late Steroid Response Study (LaSRS), which collected samples in a controlled manner from highly phenotyped patients at two sequential time points, allowing us to better understand pathogenesis and to improve our predictive power by defining a characteristic phenotype. In addition, our group has the unique ability to compare these biomarkers in BALF samples from critically ill non- ALI control patients, collected as part of a current disease pathogenesis study protocol. Due to the complexity of human biology, studying biomarkers in isolation gives us limited understanding of downstream biological consequences. Biomarker studies are enhanced by innovative techniques such as metabolomics, to broaden our understanding of systems biology at the tissue level. Identifying specific metabolic pathways linked to ALI development offers the ability to improve diagnostics and therapeutics. High- resolution metabolomics, using dual chromatography-Fourier-transform mass spectrometry now provides the ability to identify thousands of metabolites in a cost-effective and rapid way, resulting in metabolic signatures that provide insight into pathways contributing to disease pathogenesis. Previous studies analyzing plasma and exhaled breath condensate show that metabolomics can be a useful tool in patients with ALI. Our group has applied high resolution metabolomic analysis to plasma from sepsis patients, showing differences in metabolites between ALI and non-ALI patients, and we now have preliminary data of BALF to measure thousands of metabolites. Analyzing BALF offers the advantage of investigating a specific compartment of the lung where the inflammatory process is occurring. We propose to test the hypothesis that sRAGE, HMGB1 and MMP-3 and -13 work as a functioning unit and changes in levels over time in ALI patients will be associated with mortality. We will use metabolomics to extend these data and show that specific metabolic pathways are associated with biomarker activation and ALI survival. The long-term goal is to develop an affordable approach that can be used for predicting disease susceptibility, diagnosis, risk stratification, response to therapy and prognosis. Specific Aim 1 will a) determine if sRAGE, HMGB1 and MMPs are coordinately increased in the BALF of patients with ALI compared to controls at risk for ALI and provide a basis for phenotypic characterization; and b) determine whether sustained increases in sRAGE, HMGB1 and MMP levels over time are associated with mortality in ALI patients. Specific Aim 2 will develop a high-resolution metabolomic database for ALI linked to outcomes in order to: a) determine the association between specific metabolomic pathways and biomarkers analyzed in Aim 1, and b) identify candidate metabolites that differentiate ALI survivors and non-survivors. We have the opportunity to analyze BALF from the NHLBI repository that can be linked to clinical outcomes to test important biomarkers in ALI, and we have access to dual chromatography-Fourier-transform mass spectrometry to generate data on unique metabolite patterns. Completion of these studies will provide unique data on the utility of novel biomarkers and an innovative metabolomic platform that can further advance the science of ALI pathogenesis, improve therapeutic monitoring, predict clinical outcomes and facilitate targeted drug development.